The Role of Lymphoid Neogenesis in Lung Transplant Tolerance

PROJECT SUMMARY Lung transplantation remains the only available treatment for many patients, who suffer from pulmonary failure. However, outcomes after lung transplantation continue to lag behind those after transplantation of other organs. Current immunosuppressive strategies for lung transplant patients are based on protocols that have been successfully used for recipients of other organs. However, such approaches do not take into account that immune responses to lung grafts differ from other commonly transplanted organs. Utilizing new mouse models of lung transplantation we have uncovered that tolerance to pulmonary grafts is regulated locally through interactions of immune cells within lymphoid aggregates that are newly formed in the graft. This application proposes to study mechanisms how tolerance is regulated after pulmonary transplantation and will allow for the development of new therapeutic strategies for lung transplant patients.

Public health relevance
PROJECT NARRATIVE Lung transplantation is the only available therapy for numerous patients who suffer from end stage pulmonary disease. Outcomes after lung transplantation are markedly worse compared to transplantation of other organs. Identifying pathways that regulate alloimmune responses after lung transplantation is of critical importance. Our work has identified unique immune responses that set lung transplants apart from other organs. This application will utilize mouse models of lung transplantation to examine how local immune pathways that are established within newly formed lymphoid aggregates in tolerant lungs protect grafts from immunological destruction by the recipient. The proposed experiments will yield novel information that could lead to new therapies to improve outcomes after lung transplantation.